Therapeutic targeting of the SWI/SNF chromatin remodeler to regulate GBM chemosensitivity

Glioblastoma (GBM) is the most common primary malignancy of the adult brain and is among the most
devastating cancers as it is invariably lethal. The perivascular niche and necrotic regions of GBM tumors
is enriched for stem-like tumor cells called GBM stem cells (GSCs) that are highly resistant to therapy.
Within GBM tumors there are also differentiated cells that are intrinsically resistant, or acquire resistance
to, therapy. Thus, there is a critical unmet need to identify and target the molecular pathways that
promote GBM cancer stemness, which will enhance GBM sensitivity to currently approved therapies. This
proposal is premised on several of our key findings: 1) the BRG1 catalytic subunit of the SWI/SNF
chromatin remodeling complex promotes the GBM GSC phenotype and resistance to DNA alkylating
agents such as temozolomide (TMZ) used to treat GBM patients; 2) PFI-3, a small molecule BRG1
bromodomain (BRD) inhibitor (BRI), improves GSC sensitivity to DNA alkylating agents by reducing GSC
stemness; 3) next generation BRIs were developed that overcome the resistance of TMZ-resistant GBM
cell lines, including a potent BRG1-specific BRI (IV-255); and 4) BRIs increase expression of a subclass
of interferon (IFN) response genes that are predicted to enhance the anti-tumoral host immune response.
Our central hypothesis is that targeting the BRD of BRG1 selectively disrupts GBM GSCs maintenance,
which enhances GBM sensitivity to approved therapies and increases GBM immunoreactivity. In Aim 1
we will restore BRG1 expression in BRG1-KD (knockdown) GSCs and in TMZ resistant GBM cells with
either wild-type BRG or mutant BRG1 BRD that prevents chromatin binding. We will examine the role of
the BRG1 BRD in maintaining the GBM malignant phenotype and therapeutic sensitivity in vitro and in
vivo. In Aim 2 we will refine the BRI structure and develop additional small molecule BRG1 BRIs. We will
define BRI activity on cancer stemness and therapeutic sensitivity on GBM in vitro and in vivo, and
assess selectivity for BRD binding, drug-like properties and optimize BBB penetrance. The anticancer
efficacy of BRIs on intracranial GBM tumors will be tested in both immunocompromised and
immunocompetent GBM mouse models to define their impact on tumor-associated immune cells. In Aim
3 we will define how BRD targeting of BRG1 reprograms transcription to promote GBM immunoreactivity
and inhibit tumorigenesis by performing global transcriptome analysis (RNA-seq), which will be coupled
with BRG1 and RNA polymerase II specific ChIP. These BRD-regulated genes will define the BRG1-
dependent transcriptome in GSCs, and it also will identify candidate molecular pathways that could be
pharmacologically targeted with BRG1 inhibition to get cancer cell synthetic lethality. Our overarching
goal is to target BRG1 therapeutically with BRIs combined with presently employed therapies as a novel
and urgently required therapeutic approach for this devastating form of brain cancer.

Public health relevance
Despite advances in surgery, imaging and therapy, patients with the most common malignant primary brain tumor in adults, glioblastoma, have a dismal prognosis. The proposed research aims to develop novel and effective treatments for glioblastoma by targeting the bromodomain of the BRG1 subunit of the SWI/SNF chromatin remodeling complex. Defining how in glioblastoma cells the bromodomain BRG1 modifies cancer stemness, therapeutic sensitivity and tumorigenicity, while also demonstrating the feasibility of targeting this epigenetic reader as a novel therapeutic approach for treating glioblastoma.